Assessing Everyday Function in Older Adults with the Virtual Kitchen

PROJECT SUMMARY/ABSTRACT
The goal of this proposal is to develop an objective, standardized, and efficient alternative to current methods of functional assessment for older adults across the spectrum of cognitive aging, from healthy cognition to mild cognitive impairment (MCI), and preclinical and clinical Alzheimer’s disease and Alzheimer’s Disease Related Dementias (AD/ADRD). Mild functional difficulties are a strong predictor of future cognitive decline in healthy older adults and individuals with preclinical AD/ADRD or MCI and may precede impairment on traditional cognitive tests. Functional ability level is a criterion that distinguishes preclinical AD/ADRD and MCI from clinical AD/ADRD, and unlike tests of cognitive abilities, functional status generally is not as strongly influenced by race/ethnicity and socioeconomic status (SES). Consequently, information on functional status is useful for determining the validity of low cognitive test scores in non-majority older adults or older adults with low educational attainment/SES. The current benchmark standard method of functional assessment is informant report, which is subjective in nature, may be biased by cultural beliefs about aging and AD/ADRD, and requires an available and knowledgeable partner. Performance-based assessments offer advantages over informant reports but are time consuming to administer and score. Aim 1 of this proposal will evaluate the validity and reliability of a novel, portable, non-immersive, virtual-reality paradigm, the Virtual Kitchen Challenge (VKC). The VKC requires participants to complete two everyday tasks in a virtual kitchen using a touch-screen interface to select objects and sequence steps. A detailed automated score report reflecting time to completion, task accomplishment and performance efficiency is generated immediately after task completion. 180 individuals aged 65 and older with a range of cognitive abilities (healthy n = 60, MCI n = 60, mild, clinical AD/ADRD n = 60) will be administered the VKC as well as traditional cognitive tests (yielding demographically adjusted scores) and validated performance-based tasks with real objects. Informants also will be asked to complete questionnaires of functional status. We predict that the automated VKC score output will yield valid, reliable, and detailed characterizations of everyday function for participants at all levels of cognitive ability.
Aim 2 will test the hypothesis that because of its practical, ecologically valid nature and objectivity, performance-based assessment of functioning (i.e., VKC) will be less influenced by race/ethnicity, education, and SES than standard measures of cognition and informant report of function. However, if our hypothesis is not supported, demographic adjustments for interpreting VKC scores will be identified and applied. This proposal will yield an efficient and sensitive measure of everyday function for diverse older adults that may be used clinically when informants are unavailable or potentially unreliable, and may be scalable for large longitudinal studies of cognitive aging, MCI, and preclinical and clinical AD/ADRD.

Public health relevance
PROJECT NARRATIVE As the U.S. population of adults over age 65 increases and grows more diverse, highly sensitive, objective and automated measurement of functional abilities is needed to identify older adults at risk for cognitive decline and to advance our understanding of mild functional difficulties and disability. This proposal evaluates the utility of the Virtual Kitchen Challenge, a novel, portable, non-immersive, virtual reality task developed for the assessment of everyday function and characterization of functional difficulties in older adults with a range of cognitive abilities, including people with mild cognitive impairment and dementia.